An RCT of a telemedicine intervention for hypokinetic dysarthria in PD

Project Background/Rationale. The great majority of individuals with Parkinson's disease (PD) develop speech
impairments (Ho et al., 1999; Miller et al., 2007; Schalling et al., 2017), most of which are grouped together
and called hypokinetic dysarthria. Hypokinetic dysarthria is typically characterized by altered prosody (e.g.,
reduced loudness and pitch variation), phonation (e.g., breathy or harsh voice), and articulation (e.g., imprecise
consonants, centralized vowels) (Fox & Ramig, 1997; Ho et al., 1999; Hillenbrand & Houde, 1996). Changes
in speech may appear early in PD (Miller et al., 2008; Rusz et al., 2011; Skodda et al., 2013) and progress in
severity over time (Skodda et al., 2013; Skodda et al., 2009; Skodda, Flasskamp et al., 2011). Further, such
changes in speech lead to significant declines in functional communication and quality of life (Miller et al., 2006
& 2007). Pharmacological and surgical interventions that alleviate motor symptoms in PD are largely ineffective
or sometimes even detrimental for speech.
Project Objectives. Based on results from our recently completed VA SPiRE project, we propose to conduct a
pilot randomized, controlled trial (RCT) in patients with hypokinetic dysarthria in PD to assess the potential
effectiveness of a novel home-based exercise intervention with interactive automated speech response
features that encourage a higher level of speech performance. We hypothesize that patients in the intervention
program will improve in speech intelligibility and self-perceived communication ability over 6 months, as
compared with patients in a health education program.
Project Methods. A total of 104 community-dwelling veterans with hypokinetic dysarthria in mild-to-moderate
PD will be randomized to the exercise intervention or to the health education control. We will test the effects of
the intervention at 6 months for the outcomes speech intelligibility and self-perceived communication ability.

Public health relevance
Nearly 90% of people with Parkinson's disease have speech and voice disorders that negatively impact their ability to communicate effectively in daily life. This study will test the hypothesis that a combined speech and exercise intervention will improve speech intelligibility in people with Parkinson's disease and speech impairment. This approach would offer an affordable way to continue to both instruct and encourage training by veterans virtually indefinitely through our remote access technology. These findings may help VA clinicians provide optimal care for the many veterans with Parkinson's disease and speech impairment.